The role of S-glutathione in regulating cardiac myosin binding protein-C function

Project Summary
Increased oxidative stress is associated with cardiac cell dysfunction in heart disease. An unbalanced redox
state leads to an increase in the post-translational modification of S-Glutathione, which modifies cysteine
residues on key myofilament proteins, such as cardiac myosin binding protein-C (cMyBP-C). cMyBP-C
regulates contraction and relaxation of the sarcomere. The phosphorylation of cMyBP-C by Protein Kinase A
(PKA) is cardioprotective. Yet, in the failing heart, phosphorylation levels of cMyBP-C are reduced, contrary to
an increase in S-glutathionylated cMyBP-C. When cardiomyocytes were incubated with oxidized glutathione
(GSSG), myofilament calcium sensitivity increased and cross-bridge kinetics slowed. Prior experiments were
unable to isolate the specific effects of S-glutathionylated cMyBP-C (i.e., without the effects of other S-
glutathionylated proteins) nor the specific sites responsible for the functional change. Phosphorylation and S-
glutathionylation of cMyBP-C may have antagonistic effects. Incubating three N’-terminal domains of cMyBP-C
with GSSG led to a significant increase in S-glutathionylated cMyBP-C and a downregulation in cMyBP-C
phosphorylation. These results indicate that the decrease in cMyBP-C phosphorylation and consequent loss of
the cardioprotective effect of phosphorylated cMyBP-C seen in the failing heart could be due to an increase in
S-glutathionylated cMyBP-C. In addition, the anti-ischemic drug, ranolazine, has been shown to improve
diastolic function to sham levels, which correlated with S-glutathionylated cMyBP-C. These data indicate that a
currently available cardiac therapy might be useful in moderating the levels of cMyBP-C S-glutathionylation.
Thus, this proposal will identify how the interaction between phosphorylation and S-glutathionylation affects
cardiomyocyte function under normal, elevated, and therapeutically treated conditions using our novel “cut and
paste” SpyC3 mouse model. Protein domains C0C7 of cMyBP-C will be “cut” from the sarcomere using the
tobacco etch viral protease and, after washing steps, recombinant C0C7sc protein with and without modified
cysteine residues will replace its location within its endogenous location in the sarcomere. Site-directed
mutagenesis will be used to generate cysteine substitution constructs preventing S-glutathionylation at specific
residues and the functional effects of each construct will be measured using the “cut and paste” model. Dual
incubation of PKA and GSSG with and without ranolazine treatment will determine the functional effects of this
interaction. A combination of ProQ Diamond staining, immunoblotting, Phos-tag gels, and mass spectrometry
will be used to measure total modification levels and identify the site-specific modifications. Results from this
proposal will be the first to identify the functional effects of individual cMyBP-C S-glutathionylated residues and
of phosphorylation and S-glutathionylation cMyBP-C crosstalk. This research proposal will lead to a better
understanding of the effects of oxidative stress on cMyBP-C function, its potential to affect phosphorylation in
the heart, and if a currently available therapeutic might benefit hearts affected by oxidative stress.

Public health relevance
Project Narrative Post-translational modifications, or the structural modification of a protein after it is folded, of key heart contractile proteins (cMyBP-C) lead to the quick and precise regulation of the heart. These modifications appear dysfunctional in cardiac myosin binding protein-C (cMyBP-C) during heart disease. In this proposal, we aim to study the functional consequences of modifying cMyBP-C under normal conditions, elevated stress, and therapeutically treated states of the heart to better understand the consequences of these protein modifications and, ultimately, to determine if altering these modifications can lead to improved heart health.